Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The PSTC’s Administrative Core has two goals. The first is to provide infrastructural management,
administrative leadership, and research, technical, and clerical assistance so that PSTC faculty can devote as
much time as possible to their population research. The second is to arrange activities that enhance
interaction, build community, and expand exposure to population research so as to foster interdisciplinary
population science. The Administrative Core facilitates the daily activities of the Center. It also provides
indispensable support for the other cores, and coordinates with them, to deliver an efficient and cost-effective
program.